Ocular Structure & Function

OCULAR STRUCTURE and FUNCTION MODULE
Project Summary
The Ocular Structure and Function (OSF) module aims to enhance the capabilities of NEI R01-
funded investigators in advancing their vision research. This module provides a comprehensive
set of tools for ocular phenotyping through morphological analysis, light and electron microscopy,
ocular imaging, and functional vision testing. The objective of the OSF module is to improve the
effectiveness of individual investigators in performing vision research by 1) Providing essential
equipment, training, and support for histological studies, ocular imaging, and functional visual
testing. 2) Promoting collaborations and collegiality among basic and clinical vision scientists
encouraging the sharing of resources, techniques, and expertise. 3) Supporting all vision
researchers, including new faculty and both experienced and novice users. The module is fully
equipped with state-of-the-art ocular imaging and visual testing instruments, as well as
microtomes, cryostats, and histology tools. It is managed and operated by a highly experienced
manager with specific expertise in tissue processing, immunostaining, and interpreting services
for histological evaluation. Additionally, this module will provide access to prototyping services
including fabrication. The OSF module is a centralized resource for users to generate
experimental paradigms of animal models of ocular disease perform surgical procedures, follow
disease progression and test treatment ideas for development of newer therapeutics.

Public health relevance
OCULAR STRUCTURE and FUNCTION MODULE Project Narrative The Ocular Structure and Function (OSF) module will enhance the capabilities of participating NEI R01 funded investigators to conduct vision research by providing the resources to a comprehensive set of tools required for ocular phenotyping through morphological analysis, light and electron microscopy, ocular imaging and functional vision testing. Additionally, this module will provide access to prototyping services including fabrication. The OSF module is a centralized resource for users to generate experimental paradigms of animal models of ocular disease perform surgical procedures, follow disease progression and test treatment ideas for development of newer therapeutics.